POST APICAL LEFT VENTRICULOTOMY FOR CLOSURE OF SEPTAL DEFECT

The objective of this research is to assess the intermediate outcome in the 13 patients who have had apical ventriculotomy for closure of muscular ventricular septal defects at UMMC between 1/1/88 and 11/1/94. Outcome will be assessed by quantifying left ventricular function, presence of residual ventricular septal defects, and presence of electrocardiographic abnormalities.